Potential of Dried Blood Spots for Measurement of Alzheimer's Disease Biomarkers

PROJECT SUMMARY/ABSTRACT
The rapid development of ultrasensitive immunoassays has made it possible to measure biomarkers for
Alzheimer’s disease (AD) in blood with high accuracy, allowing for minimally invasive detection of disease
pathology. A major advantage of using easily repeated measures of AD, as available with minimally
invasive blood biomarkers, is the greater sensitivity and reliability for detecting within person change. In
clinical trials this can dramatically reduce sample sizes needed to detect effect and potentially shorten the
trial period by detecting treatment effects earlier. Collection of venous blood through phlebotomy is,
however, still a medical procedure performed by trained staff requiring scheduled in-person visits in-clinic,
or more rarely at-home, followed by sample processing in a timely manner. We will investigate and validate
the use of dried blood spot (DBS) samples obtained through self-administered fingerstick, which can be
collected at home by study participants themselves and be sent to the lab by mail, to measure blood-based
biomarkers of AD. DBS has successfully been used to measure many analytes including a wide variety of
proteins and peptides, but it is not established whether whole blood is a comparable matrix to plasma/serum
for AD biomarker measurements and how stable DBS measurements of such biomarkers are over time. Our
goals are to 1) optimize fingerstick collection methods for DBS samples and to perform fit-for-purpose
validation of assays and parameters of measurement for pTau217, GFAP, and NfL, three key biomarkers
reflecting AD pathology and neurodegeneration, in capillary DBS samples; 2) establish if DBS
concentrations of the three biomarkers correlate with concentrations in paired plasma samples, and 3)
evaluate the stability of measurements (precision) in repeated samples over a fourteen-week timeframe.
The overarching goal of our study is to understand if frequent repeated measures of blood biomarkers in
DBS samples can be incorporated as a sensitive measure for AD pathology in clinical trials of disease
modifiers as well as in longitudinal and epidemiological observational research. The accessibility of DBS
furthermore promises to increase diversity by being more inclusive, especially of ethnoracially, culturally,
and geographically under-represented groups that traditionally experience more barriers to participate in
clinical research.

Public health relevance
PROJECT NARRATIVE Recent technology developments have made it possible to measure biomarkers for Alzheimer’s disease (AD) in blood with high accuracy, allowing for minimally invasive detection of disease pathology for early diagnosis and to follow change over time. Collection of venous blood through phlebotomy is, however, still a medical procedure performed by trained staff requiring scheduled in-person visits in clinic, or more rarely at- home, followed by sample processing in a timely manner. We will investigate and validate the use of dried blood spots (DBS), which can be collected at home by study participants themselves and be sent to the lab by mail, to measure blood-based biomarkers of AD and determine the intra-individual short-term stability of biomarkers in repeated DBS samples to provide a baseline for incorporation in clinical trials as well as in longitudinal and epidemiological observational research.